Indiana Diabetes Research Center

Abstract (Overview)
The mission of the Indiana Diabetes Research Center (IDRC) is closely aligned with key goals articulated in
the NIDDK Strategic Plan for Research and rests on four main pillars of activity: 1) robust support of
translational research in diabetes and related metabolic disorders; 2) effective stewardship of resources and
promotion of research that emphasizes rigor and reproducibility; 3) facilitating collaboration; and 4) support of
training and workforce development. The IDRC includes a community of 110 investigators, located at the
Indiana University School of Medicine (IUSM) and its affiliated institutions, who represent four integrated
research themes: Cellular & Molecular Metabolism; Complications of Diabetes & Obesity; Islet Function &
Survival; and Nutrition & Physiology of Diabetes & Obesity. To support this community, the IDRC leverages
federal, institutional, and philanthropic funds to oversee Research Cores that dynamically evolve to meet the
emerging needs of our Research Base, a Pilot & Feasibility Program that provides financial support and
mentoring, and an Enrichment Program that serves as a focal point for information exchange and
collaboration. Four IDRC Research Cores drive research and facilitate collaboration and innovation. These
Cores include the Microscopy and Islet & Physiology Cores, which facilitate cellular and small animal research,
a Translation Core to advance clinical and human tissue research, and a Data & Analytics Core, which
provides support for studies with multiple data types and electronic health records. The Administrative Core
oversees the governance of the IDRC, with input from an Executive Committee and Internal and External
Advisory Boards of diabetes/metabolism research and institutional leaders. Anchored by these groups, the
IDRC advocates for its diabetes and metabolic disease Research Base and serves as an exemplary
contributor to the NIDDK network of Diabetes Research Centers (DRC), supporting outreach, technology
development, knowledge exchange, and collaborations with other DRCs. The IDRC will achieve the following
aims:
(1) Develop and sustain Research Cores that facilitate implementation of state-of-the-art
methodologies and promote rigor and reproducibility.
(2) Enhance a highly collaborative environment that promotes learning and encourages interaction
among IDRC investigators and between the IDRC and other Diabetes Research Centers.
(3) Support the innovative research of a burgeoning pool of superb investigators with the potential to
become future leaders in diabetes research.
(4) Build and strengthen the diabetes research base, support infrastructure to ensure ongoing growth
and innovation, and engage with the local community to raise diabetes awareness and involvement.

Public health relevance
Project Narrative The goal of the Indiana Diabetes Research Center (IDRC) is to leverage resources, a highly talented pool of basic, translational, and clinical researchers, and a rich environment of learning and collaboration to tackle the causes, diagnoses, and treatment of diabetes and related metabolic disorders and their complications. Guiding principles of the IDRC are pursuit of work that spans the translational continuum and emphasizes rigor, reproducibility, and effective stewardship of resources, with an emphasis on building a community at the Indiana University School of Medicine and its affiliated institutions that values diverse perspectives and promotes workforce development and collaboration. .